GMP Production and Extended Toxicology of an Oral Formulation Drug for Alzheimer's Disease

ABSTRACT
This is an administrative supplement application to U01 AG076480, to request costs due to unforeseen
circumstances. These additional proposed activities are within the scope of the U01 project but were
unexpected at the time of award. For example, the length and breadth of the COVID-19 pandemic were not
anticipated by public health or other government agencies. The pandemic caused several downstream hurdles,
including scheduling delays with CROs, supply chain shortages, and dramatic cost increases. The effect was
profound for the GMP drug manufacturing and testing (aim 1) and the extended GLP toxicology studies (aim
2). Therefore, we are requesting an administrative supplement to allow us to complete the specific aims and
meet the milestones of our AG076480.

Public health relevance
NARRATIVE We have developed a brain-penetrant, small molecule drug candidate, called MW189, that targets dysregulated inflammation and attenuates brain dysfunction. The proposed project will fill the remaining gaps necessary to bring MW189 to a future clinical study in Alzheimer’s patients. MW189 has the potential to be a first-in-class disease-modifying therapy for Alzheimer’s disease and related disorders.